Alcohol and Cannabis Misuse Among Assault-Injured Emerging Adults

Alcohol and Cannabis Misuse Among Assault-Injured Emerging Adults
NIDA R34
PI: Edouard Coupet
Project Summary: Substance misuse and assault injury, defined here as an intentional injury inflicted by another
person not considered to be a boy/girlfriend, fiancée, or spouse, both represent substantial public health and
safety burdens in the U.S. Emerging adults (18-25 y/o), an age group noted to experience significant
neurobiological and psychosocial development, are disproportionately at risk for both substance misuse and
assault injury. Assault-injured emerging adults with substance misuse are associated with increased risk of
recurrent assault injury, morbidity, and mortality compared to those without substance misuse. Critical knowledge
deficits exist in the shared psychosocial risk factors such as both self-efficacy to reduce substance use and
perceived peer and familial norms of substance use, in the context of assault injury. Filling this knowledge gap
is important because: 1) substance misuse represents a crucial, modifiable risk factor for assault injury and 2)
there is a paucity of interventions that target substance use in this high-risk population that can be delivered at
sites of acute medical care such as the emergency department (ED). Brief motivational interventions, including
the Brief Negotiation Interview (BNI), have been found to be effective in reducing alcohol and cannabis use in
the ED setting. The BNI enhances motivation to reduce alcohol and/or cannabis use and engage in treatment
referral. The goal of this proposal is to adapt and pilot test the BNI for use among assault-injured emerging adults
with alcohol and/or cannabis misuse in the ED. To accomplish this, we will elicit these shared psychosocial risk
factors (i.e., self-efficacy and perceived peer and familial norms) that contribute to both alcohol and cannabis
misuse in the context of assault injury. Aim 1 will be to assess self-efficacy, perceived peer and familial norms,
and motivation to reduce alcohol and/or cannabis use and engage in treatment referral, among assault-injured
emerging adults. Aim 2 will be to adapt the BNI for use among assault-injured emerging adults with alcohol
and/or cannabis misuse in the ED. Aim 3 will be to determine the feasibility and acceptability of the adapted BNI
in the ED through a randomized pilot trial comparing those who have received the adapted BNI and treatment
referrals to a referrals-only control group. Overall, the findings of this proposal will provide the necessary pilot
data for a fully powered effectiveness trial of the adapted BNI in a subsequent R01 application.

Public health relevance
Alcohol and Cannabis Misuse Among Assault-Injured Emerging Adults NIDA R34 PI: Edouard Coupet Project Narrative: Substance misuse and assault injury are major public health and safety crises among young adults. This project will determine the shared risk factors of both substance misuse and assault injury to inform the development of a brief motivational intervention that targets substance misuse in this high-risk population. This pilot trial will provide important information to inform a larger clinical trial.